The mechanisms and functions of nuclear spacing in muscle development

Summary
Nuclear movement is evolutionarily conserved throughout eukaryotes, a testament to the fundamentally
important nature of this process. The importance of this process is most evident in syncytial muscle cells,
which move their nuclei to maximize the distance between each nucleus and its neighbors, a process thought
to establish a series of independent myodomains. Furthermore, mispositioned nuclei in muscle cells are
prevalent in muscle disease. In recent years, dozens of proteins have been implicated in the movement and
spacing of nuclei, but their mechanisms of action, and the consequences of nuclear spacing, remain elusive.
The goal of the proposed research is to fill this critical gap in knowledge. Specifically, we will define the
features of the microtubule cytoskeleton that are critical for both moving nuclei to establish the spacing and
anchor nuclei to maintain the spacing. Only recently have the molecular, physical, and imaging tools emerged
to make it possible to address these mechanistic questions in vivo. In the proposed research we will generate
and test mutant proteins that target the microtubule specific functions of pleitropic proteins to isolate the
specific contribution of the microtubule interactions. We will then apply our recently developed analyses of
nuclear movement and microtubule organization combined with classical genetic approaches to determine the
genetic and molecular mechanisms by which these factors move and anchor nuclei during muscle
development. Within this work we will test whether two emergent properties of the microtubule cytoskeleton,
branching and sliding contribute to nuclear spacing in muscle. Finally, we will directly tie these data to disease
pathogenesis by determining how dystrophin, the gene mutated in the most common and debilitating muscle
disease contributes to these processes. Successful completion of these aims will provide the first mechanistic
understanding of nuclear movement in an in-tact developing muscle cell making it possible to manipulate
nuclear spacing to understand how the position of the nucleus impacts its function.

Public health relevance
Project Narrative Progress in treatment of impaired muscle function is limited in part by relatively poor understanding of the principles that govern the development of these specialized cells. One unique and dramatic feature of skeletal muscle cell development is the energetically expensive, long range movements of nuclei that establish myodomains with individual nuclei regulating each. The proposed research will identify the mechanisms that drive nuclear movement, the mechanisms that maintain nuclear spacing during muscle growth, and connect these mechanisms to muscle disease.